Antibodies, B cells and resistance to human cryptococcosis

HIV-associated immunosuppression portends high risk for cryptococcal meningitis (CM). Despite progress that
has increased HIV testing and anti-retroviral therapy (ART) availability in resource-limited settings, the
incidence and mortality of CM remain very high. In addition, ART can elicit immune reconstitution inflammatory
syndrome (C-IRIS), and CM also occurs in HIV- persons, including recipients of solid organ transplants and
biologics. There are no host biomarkers to predict which HIV-infected (HIV+) patients will develop CM or C-
IRIS. We are interested in the role antibody (Ab) immunity may play in resistance to CM, which is rare in
people with intact immunity. We have contributed significant knowledge in this area, including recent data
showing lower natural Laminarin (a β-glucan)-binding Ab levels in HIV+ patients with C-IRIS and positive serum
cryptococcal antigen tests. Studies of HIV+ and HIV- patients revealed perturbations in Ab repertoires of
patients with CM and C-IRIS, and lower IgM memory B cell levels in patients with CM. In mice, IgM memory
homologs, B-1 cells and/or naïve IgM enhanced resistance to CM. These cells make Abs that bind microbial
carbohydrates, e.g. the β-glucans on the Cn cell wall. The goal of this project is to probe the link between
natural Ab and B cell responses to Cn and resistance to CM. We hypothesize CM risk will associate with
deficiency of specific Cn- and/or β-glucan-binding Abs, stemming from B cell repertoire pertubations. Our aims
are 1] To characterize Cn- and β-glucan-binding Abs of patients with and at risk for CM and C-IRIS, isolate
monoclonal antibodies (huMabs) from normal persons and test their efficacy in mouse models. 2] To
determine the ability of huMabs and GXM- and β-glucan-binding Abs to 1] exert direct effects on Cn viability
and biology, and/or 2] mediate human effector cell Cn phagocytosis and/or killing. 3] To analyze B cell subsets,
VH/VL repertoires, and transcriptional pathways of patients with and at risk for CM and C-IRIS, and controls,
and use statistical modeling to identify signatures of CM risk. Knowledge gained from this project will inform
tools to predict CM and C-IRIS risk, overcome roadblocks to diagnosis and therapy, provide new insight into
the pathogenesis of CM, and inform development of immunotherapy and vaccines.

Public health relevance
PUBLIC HEALTH SIGNIFICANCE Cryptococcus neoformans is a fungus that causes a devastating form of meningitis that occurs most commonly in HIV-infected patients with profound T cell deficiency, but also occurs in patients with organ transplants, on biologics, and people with no apparent immune deficiency. Although anti-retroviral therapy has reduced the risk of cryptococcal meningitis (CM) in resourced areas, CM continues to ravage HIV-infected patients in Africa, Asia and other areas, even with increased availability of anti-retroviral and anti-fungal therapy. The 6- month survival of CM in resource-limited settings is 45-55%. This is worse than glioblastoma multiforme (66% 2-year survival). At present, there is no way to identify patients who will develop cryptococcosis. The goal of this application is to identify a risk profile to help determine which patients are at risk for CM. This will have a significant impact on prevention, diagnosis, and care of patients with CM and be a major public and global health advance.